Biophysical studies of viral membrane fusion proteins

SUMMARY
Hemagglutinin (HA) is an envelope glycoprotein that resides on the surface of influenza A virus (IAV) particles.
HA mediates attachment of IAV virions to the cell surface through interaction with sialic acid (SA) moieties.
Following internalization by endocytosis, the acidic environment of the late endosome triggers conversion of
HA from a metastable prefusion conformation to a highly stable postfusion coiled coil. This cascade of
conformational changes in HA results in fusion of the viral and endosomal membranes. Importantly, exposure
of IAV to acidic pH prior to attachment to a cellular membrane prematurely converts HA to the postfusion
conformation, which renders IAV noninfectious. Therefore, ensuring proper timing of HA conformational
changes is critical to the life cycle of IAV. While endpoints of the HA conformational changes during membrane
fusion are well characterized, recent structural data is beginning to identify intermediate states. However, the
HA conformational trajectory that leads from prefusion to postfusion is not yet validated, nor has the timing of
membrane fusion with respect to HA conformation been determined. The funded project leverages the
combined strengths of the Munro and Somasundaran laboratories in cutting-edge single-molecule Förster
resonance energy transfer (smFRET) imaging, single-virion fusion assays, cryoelectron tomography (cryoET),
and computational approaches to address these questions in viral fusion. The funded project relies heavily on
the application of advanced, quantitative fluorescence microscopy within the Munro laboratory. With
institutional support from UMass Chan Medical School, the Munro laboratory has custom built a microscope
specifically designed to conduct the proposed experiments. The requested Administrative Supplement for
Equipment Purchases will provide upgrades to the existing microscope. These upgrades will address
shortcomings of the microscope, which limit the ability to successfully complete the proposed Aims, and which
were not foreseen at the time of application.

Public health relevance
NARRATIVE Influenza hemagglutinin is a model system for studying the mechanism by which enveloped viruses fuse membranes during entry into cells. The proposed research will lead to a better understanding of the mechanism of influenza and SARS-CoV-2 entry, specifically, and class-I viral membrane fusion in general.